Genomics Core

SUMMARY
A critical gap often exists at institutions serving underserved health disparity populations and underrepresented
students (ISUPS) between access to Genomics technologies and the high costs associated with the required
instrumentation, technical proficiency, and analytical expertise. The Genomics Core (GC) addresses this gap
by providing expert and affordable access to high-throughput genomics technologies on a reduced fee basis
for all Partnership investigators. The GC benefits the entire Partnership by providing innovative approaches to
explore early project ideas, and by working with Partnership investigators and their trainees to facilitate the use
of genomics technologies to build sustainable cancer biology and cancer disparities research. To accomplish
these goals, the GC (through the auspices of the Center for Personalized Cancer Therapy, CPCT) provides
front-line genomics-related technologies, as well as bioinformatics support for data analysis, to Partnership
investigators through an affordable reimbursement model. The GC proposes to accomplish these goals
through the pursuit of four specific aims designed to build capacity for biomedical and cancer research and
training at UMass Boston by bridging a gap in the availability of cutting-edge genomics-based tools; support
Partnership investigators who wish to pursue early project ideas, especially those that require innovative
and/or technically challenging genomics approaches; bridge a training gap between students and high-level
genomics-based technologies, and provide bioinformatics analysis of data generated in the core. In this
application, the GC specifically supports FP2: Targeting androgen receptor signaling in prostate cancer in men
with African Ancestry – Steven Balk (DF/HCC - BIDMC) and Changmeng Cai (UMass Boston) and PP2: High
frequency of CHD1 loss in BRCA2-deficient African American prostate tumors drives treatment resistance –
Zoltan Szallasi (DF/HCC - BCH) and Shailja Pathania (UMass Boston).